Complementary and Integrative Health for Pain in the VA: A National Demonstration Project

PROJECT SUMMARY/ABSTRACT
Background. Over half of Veterans report musculoskeletal (MSK) pain, often with mental health comorbidities.
Complementary and integrative health (CIH) therapies are important non-pharmacologic treatment options for
these conditions. However, CIH is not widely available at the VA. Also, practitioner-delivered therapies (i.e.,
acupuncture or chiropractic) are promising, but providers would like patients to be more active in their pain
management by using self-care (i.e., meditation, tai chi, yoga) instead of relying on practitioner-delivered care.
A critical question for the field is whether adding self-care CIH to practitioner-delivered CIH is a more effective
approach than either strategy alone. However, we are unaware of anyone examining this. Also, to-date,
studying CIH in large VA samples has been difficult because few facilities capture CIH use with codes in their
electronic health records, and very few use the VA's standardized codes, preventing multi-site studies. In 2016,
Congress passed the Comprehensive Addiction and Recovery Act mandating expansion of CIH therapies in
VA. In response, 18 VA regional networks committed $5 million/yr to implement CIH therapies at 18 sites
beginning in 2018, focusing on five evidence-based therapies: acupuncture, chiropractic, Tai Chi, mindfulness,
and yoga. The VA's Office of Patient Centered Care and Cultural Transformation (OPCC&CT) will oversee this
effort, including the data collection efforts targeting 1,000 CIH users from each of the 18 sites. We propose
addressing the above gaps by continue our longstanding collaboration with OPCC&CT to capitalize on 1) the
2018 rollout of CIH in 18 VA sites and 2) our two current national/multisite studies of the effects of CIH, one on
MSK pain and the other which integrates CIH patient reported outcomes (PROs) measurement into clinical
care. We propose a large-scale pragmatic comparative effectiveness clinical trial to assess CIH. In the UG3
Planning Phase, as the 18 sites begin implementing CIH, we will develop and implement data collection
instruments and processes that we are currently piloting to capture CIH use and PROs: 1) pain and its intensity
and interference, 2) global physical and mental health and 3) fatigue. We also will examine opioid use. To
inform that measurement, we will use multiple strategies, including an Advisory Board. In the UH3
Implementation Phase, we will conduct a 3-arm pragmatic trial using an encouragement design to assess the
longitudinal comparative effectiveness of: 1) practitioner-delivered care (acupuncture or chiropractic
care) combined with self-care (Tai Chi, meditation/mindfulness or yoga) compared to 2) practitioner-delivered
care alone or 3) self-care alone. We will examine outcomes at 3 and 6 months for OPCC&CT's target sample of
18,000 CIH users. We will use randomized “nudges” (e.g., educational brochures with class listings) tailored to
each site to encourage Veterans who use one type of CIH to consider a combination of therapies.

Public health relevance
Project Narrative This study aims to improve the health and satisfaction of Veterans with chronic musculoskeletal pain by better understanding the effectiveness of five types of evidence-based complementary and integrative health, which are non-pharmacologic options to treat their pain and comorbid mental health conditions.